Keratinocyte-dependent regulation of innate immune responses in inflamed skin

SUMMARY
Inflammation, dysregulated innate immune responses, and loss of barrier function underlie several skin
conditions including psoriasis, atopic dermatitis, hidradenitis suppurativa, and pachyonychia congenita.
Compelling evidence now shows that signals regulating inflammation and innate immunity are produced and
secreted by stressed keratinocytes making up the skin epidermis. How the relevant signals are generated in
keratinocytes, their cellular targets, and the pathways involved in ensuring proper regulation of inflammation
and innate immunity in healthy skin tissue, and their dysregulation in disease, remain poorly understood.
This multi-PI proposal takes advantage of the complementary expertise of two established investigators and
is supported by a strong body of unpublished findings, obtained collaboratively, showing that (i) keratinocyte-
derived and keratin-dependent signals regulate the spatial and temporal pattern of neutrophil influx into skin
undergoing sterile inflammation; (ii) keratinocytes transiently adapt to prior exposures and are able to amplify
responses in the setting of repeated aggressions; (iii) the stress response keratin 17 (K17) acts as a positive
regulator of neutrophil infiltration by mediating the sustained activity of protein kinase C a (PKCa) in
activated keratinocytes; and (iv) keratin 16 (K16) - another stress response keratin – acts as a negative
regulator of neutrophil infiltration and inflammation. We hypothesize that stressed keratinocyte-derived
signals engage and regulate cellular effector of innate immunity in skin, and that this is highly relevant to
several inflammatory skin disorders. We further hypothesize that K16 and K17 act through unique cis-acting
determinants to differentially regulate PKCa activity, neutrophil infiltration and other aspects of innate
immunity in stressed skin tissue. The proposal tests these hypotheses through three specific aims. Aim 1
seeks to compare the spatiotemporal pattern of immune cell infiltration and PKCa activity in mouse skin null
for either keratin 16 or 17 following exposure to stressors. These animals studies will be corroborated by
studies in N-TERT human keratinocytes in culture. Aim 2 seeks to identify, in cell culture models, the cis-
acting determinants responsible for the differential impact of K16 and K17 protein on PKCa activity,
neutrophil stimulation and other cellular aspects of inflammation and innate immunity. Finally, Aim 3 will
define the contribution of other key cellular effectors of innate immunity, specifically macrophages, in
mediating the keratinocyte- and keratin-dependent amplification of neutrophil influx in stressed skin in vivo.
The mechanistic insight that we stand to gain from completing this project is predicted to lead to a deeper
understanding of the pathophysiology of chronic skin inflammatory disorders, yield novel and more reliable
biomarkers and, possibly, new strategies to treat skin diseases.

Public health relevance
PROJECT NARRATIVE The dysregulation of inflammation and immune responses plays a key role in the pathophysiology of skin disorders, including psoriasis, atopic dermatitis, hidradenitis suppurativa, and pachyonychia congenita. This project is focused on identifying keratin-dependent pathways in epidermal keratinocytes and understanding their role in regulating the spatiotemporal pattern of neutrophil infiltration and engagement of other cellular effectors in inflamed skin. Completion of the proposed studies will generate new insight into skin homeostasis and may help identify new biomarkers and new targets for the diagnosis and treatment of skin disorders.